PRE-SYMBOLIC COMMUNICATION

The proposed studies represent an extension of an ongoing program of research. The major objectives of this research are to describe the extant communication abilities of children and adults with severe to profound mental retardation; and to identify the factors that are associated with the attainment (or nonattainment) of specific communication and language abilities by such individuals. The proposed studies will address five specific aims related to these overall objectives that have been identified on the basis of the applicant's current and previous research. All of these aims relate to a proposed model of communication development in this population that identifies a number of critical "cusps" that have apparently been traversed by some individuals in the course of their communication development; but that represent the end point of that development for other individuals. The first three specific aims are: 1) To describe the extant communication abilities of a sample of young prelinguistic children with severe to profound mental retardation; 2) To describe the rate and sequence of communication skill development by these same subjects over a five year observational period; and 3) To determine whether specific child and/or environmental variables are significantly related to differential communication skill attainments by these subjects at the end of this observational period. These three aims will be addressed through a five year, repeated measures design involving 25 prelinguistic young children (ages 4 to 5 years at onset of observations) with severe to profound mental retardation. A battery of measures, including standardized assessments and direct observations of parent-child interaction, will be administered to each subject at least every six months, and more often with subjects who are arriving at the identified cusps at a faster pace. Specific aims 4 and 5 are to determine whether specific intervention procedures are effective in helping individuals with severe mental retardation make the transition from presymbolic, distal gesture communication to referential symbolic communication (Aim 4); and across one or more other critical cusps, including that between contact gesture and distal gesture communication, and/or that between single symbol and linguistic (syntactic) communication (Aim 5). Subjects in these studies will include both children and young adults; and single subject research designs will be used to determine the effectiveness of specific treatment approaches for each subject.